Targeting kidney resident macrophage niche filling to slow cystic kidney disease

PROJECT SUMMARY/ABSTRACT
Autosomal dominant polycystic kidney disease (ADPKD) is the most commonly inherited kidney disease in the
world. It is characterized by large fluid-filled cysts that disrupt kidney function, eventually leading to end stage
kidney disease. Previous literature indicates that kidney resident macrophages (KRM) are cyst-associated in
human clinical samples and are also found in cystic regions of ADPKD mouse models. KRM accelerate ADPKD
as depletion of KRM reduces cystic index and disease progression in mouse models of the disease. Together,
these data suggest that targeting KRM may have a clinical impact in patients. Unfortunately, it is currently not
feasible to give patients macrophage depleting agents for long periods as these compounds lack specificity,
depleting macrophage populations in multiple tissues. This is an important point as macrophages perform critical
functions as part of an organism’s innate immune defense. Additionally, ADPKD progresses slowly and patients
experience gradual cyst growth and loss of kidney function over several decades of life, thereby requiring long-
term intervention. These data highlight that alternative approaches for long-term, kidney-specific resident
macrophage depletion are desperately needed. In this application, I propose to study niche filling as a means to
achieve long term, kidney specific resident macrophage depletion. This will be achieved by determining the
mechanism of KRM niche filling after temporary depletion and through identification of factors, such as Cx3cr1,
that we propose are critical for KRM niche filling. The central hypothesis of this proposal is that following
temporary depletion, the KRM niche is repopulated via the recruitment and differentiation of bone marrow-
derived Ly6chi monocytes and that this process requires Cx3cr1. In Aim 1, I will map out the kinetics and
mechanism of KRM niche after temporary depletion in a mouse model of ADPKD. In Aim 2, I will test if loss of
Cx3cr1 in monocytes is able to delay KRM niche filling and the progression of cystic disease. My long-term goal
is to understand the mechanism of KRM niche filling and translationally apply KRM-centric findings to clinical
cases of ADPKD.

Public health relevance
PROJECT NARRATIVE Kidney resident macrophages (KRM) are known accelerators of ADPKD as their depletion slows cyst progression. In this application, I will study the kinetics and mechanism of KRM niche filling after temporary depletion in an ADPKD mouse model to identify possible means to achieve long-term, kidney specific resident macrophage depletion. This work may provide a template to develop long-term, tissue specific, resident macrophage depletion in the kidney, something that will be of broad interest to the macrophage and kidney community.